A culturally-tailored dietary trial for cardiometabolic health in Puerto Rico

Project Summary
The PREDIMED trial produced strong evidence showing that adhering to a Mediterranean dietary
pattern is associated with lower risk of type 2 diabetes (T2D) and cardiovascular disease (CVD). Yet such a diet
may not be familiar or accessible to populations of different cultural backgrounds. Few clinical trials have
examined the mechanisms that contribute to cardiometabolic improvements, posited to be through changes in
the metabolome profile, psychosocial factors, or access to food. Our overall goal is to prevent CVD and T2D
among high-risk adults in the United States (US) territory of Puerto Rico (PR), where cardiometabolic burden
is excessive, by promoting a healthy, accessible, and culturally appropriate diet. In response, we led PROMED
(Puerto Rico-Optimized Mediterranean-like Diet #NCT03975556), a 4-mo, 2-arm, parallel pilot and feasibility
randomized trial that tested the efficacy of a culturally tailored intervention vs. standard healthy eating
program in improving cardiometabolic risk factors in 44 adults in PR. Participants highly rated PROMED’s
cultural acceptability, practicality, and satisfaction. The short-term benefits on blood pressure and HDL-C need
to be tested long-term. We therefore propose to test these mechanisms and the intervention’s efficacy by
expanding PROMED to a 2-year, 2-arm, parallel randomized clinical trial among 250 free-living adults aged
30-65y in PR with at least one dysregulated risk factor but free of CVD or T2D. The intervention group will
receive culturally tailored portion-control advice through monthly individual counseling reinforced with daily
text messages, and a monthly supply of legumes, vegetable oils, and locally produced fruit and vegetables.
Participants in the control arm will receive standard portion-control non-tailored nutritional counseling in
monthly individual sessions reinforced with daily text messages and monthly supermarket vouchers, but no
foods. Primary outcomes are a cardiometabolic improvement score (CIS) denoting improved cumulative risk
factors at a clinically significant value and 10-year atherosclerotic CVD (ASCVD) risk estimated from the
pooled cohort equation. We aim to determine the biological mechanisms mediating the efficacy of PROMED vs.
control by measuring plasma metabolite signatures that predict changes in CIS and 10-year ASCVD risk; assess
change and mediation of psychosocial factors (self-efficacy, self-control, intent) on CIS, and ASCVD; and
ascertain changes in food security, access, and expenditure by group, and effects on diet, CIS, and ASCVD. As
an exploratory aim, we will assess spillover effect of the intervention by inviting one household member of 70
participants at random for clinical and laboratory assessments. We expect PROMED will improve participants’
cardiometabolic health and elucidate posited mechanisms of action of a healthy diet. This new rigorous
evidence will enhance dietary guidelines and shift the paradigm from recommending generalized diets to
adapting guidance according to the biological, psychosocial, and social needs of diverse populations.

Public health relevance
Narrative Adhering to a Mediterranean dietary pattern can reduce the risk of type 2 diabetes (T2D) and cardiovascular disease (CVD); yet there is scant evidence of this benefit in non-Mediterranean populations for which this diet may not be familiar or accessible, as well of trials examining the mechanisms that contribute to these cardiometabolic improvements. PROMED is a randomized clinical trial among adults in Puerto Rico that will test the efficacy of a culturally-tailored intervention using traditional foods vs. a standard healthy eating program in improving cardiometabolic risk factors in 2yr, and assess if these effects are mediated by metabolite changes, psychosocial factors, or food security and access. PROMED is expected to generate evidence on posited mechanisms of action of a healthy diet and to shift the paradigm from recommending generalized diets to adapting guidance according to the biological, psychosocial, and social needs of diverse populations.